Place Matters - Adaptable Solutions to Violence at the Community Level

PROJECT SUMMARY / ABSTRACT
Gun and domestic violence have both drastically increased in US cities following the coronavirus
(COVID-19) pandemic, including in gun violence involving children and unintentional firearm deaths in
youth. Furthermore, the pandemic drastically increased the already wide gap between exposure to
violence for Black and other minoritized youth. The broad objective of the proposed research is to
examine the short- and long-term impact of vacant and abandoned property remediation on violence
before and during the COVID-19 pandemic and in the years that follow, with a specific focus on how
vacant and abandoned property remediation may have buffered violence and psychological stress
during the pandemic. Although there is a growing evidence-base to prevent violence, including youth
and family violence, there is now an unprecedented opportunity to examine the impact that place-
based, population-level interventions have had on trends in violence during and following large
perturbations to urban systems, including, very prominently, the COVID-19 pandemic. The proposed
work adds significantly to our ongoing place-based cluster randomized trial aimed at primary prevention
of violence among youth and families (R01HD095609). Expanding our efforts by continuing treatment
and following our trial clusters for a longer period of time (nearly three years)—especially given the
impact of COVID-19—will provide valuable new information for a growing number of cities, beyond
simply New Orleans, who are launching place-based approaches to violence prevention. This unique
opportunity to learn more about how to adapt and improve such approaches by studying what
happened during the height of the pandemic and in the years that follow will uniquely advance our
understanding of such programs during future large-scale events such epidemics, extreme weather due
to climate change, or other large perturbations that quickly affect the daily lives of entire cities and will
continue to do so with increasing frequency.

Public health relevance
Public Health Relevance: The goal of this administrative supplement is to examine the short- and long-term impact of vacant and abandoned property remediation on violence before and during the COVID-19 pandemic and the years that follow, with a specific focus on how vacant and abandoned property remediation may have buffered violence and psychological stress during the pandemic and a hurricane. Upon successful completion of the proposed objectives, we will have a deeper understanding of how to adapt and improve such placed-based approaches throughout the pandemic and a natural disaster, allowing us to advance our understanding of such programs during future epidemics, extreme weather due to climate change, or other large perturbations that quickly affect the daily lives of entire cities and will continue to do so with increasing frequency.